Shared Resource Core: Computational and technology development for spatial expression analysis.

Shared Resource Core. Computational and technology development for spatial expression
analysis
SUMMARY
The Shared Resource Core will support the CSBC Research Center for Tumor-Immune Systems Biology by
bringing the latest generation of profiling technologies to bear on all three scientific Projects. Emerging spatial
technologies are providing powerful means of interrogating the cancer microenvironment and assessing tumor-
immune interactions in tissue context. The Shared Core will deliver a set of key technologies, including targeted
methods for multiplexed protein and RNA transcript measurement at subcellular spatial resolution, and lower-
resolution transcriptome-scale approaches. These platforms have already been established in-house and will be
further optimized for the contexts contained in this proposal. The Shared Resource Core will make these
approaches available across Projects and work to optimize and customize for each tissue and biological
question, in addition to disseminating tools broadly in the community.